X-Ray Novel Imaging Optics and Methods

This project currently has two components. One is x-ray diffraction study of intact tissue samples for the identification of calcium minerals. This component answers questions from Dr. Manfred Boehm's group about the composition of tissue calcification in surgical samples from patients with the rare genetic disease ACDC.
A second component of this project is to explore basic contrast mechanisms for x-ray imaging that contain chemical or biological information about the tissue. Earlier we have explored the processes of diffraction and refraction of the x-ray wave. This year we continue to explore other processes. We found that new instrumentation and measurement methods are needed to detect and quantify certain processes that have not been studied in the past. We rely on our engineering experience in MRI and x-ray imaging to develop these methods.